Modelling the dynamics of spontaneous clonal hematopoiesis in pet dogs during cancer therapy

PROJECT SUMMARY
Somatic mutations with leukemogenic potential confer selective cellular advantages leading to clonal expansion
of hematopoietic stem cells, a phenomenon termed “clonal hematopoiesis” (CH). CH represents a premalignant
lesion associated with aging, as it occurs in >10% of people 70 years of age or older, conferring an approximate
20-fold increased risk for future hematologic malignancy. Importantly, cancer patients with CH that undergo
chemotherapy or radiotherapy exhibit a substantially increased risk for secondary neoplasia. In one study of
750+ human cancer patients undertaken by Dr. Bick (mPI), a greater than 5-fold increase in CH was observed
for those that underwent radiation treatment (with or without chemotherapy) compared to those that did not
receive radiation. Given its expanding role in cancer survivorship, there is a growing need for novel therapeutic
strategies that target CH to mitigate risk for future malignancy and modify its potential impact on cancer
treatment. However, a major barrier to better understanding the influence of CH on cancer pathophysiology
remains the absence of an in vivo model system that recapitulates the development and evolution of CH during
aging, tumorigenesis and subsequent cancer treatment. Studies of aged (>25 months) mice reveal that CH is a
relatively rare event, suggesting that their comparatively short lifespans preclude its development. Genetically
engineered mouse models have been generated in which hematopoietic stem cells typically carry one of the
known human CH driver genes, but these typically necessitate bone marrow transplantation (often
myeloablative) which induces a variety of systemic changes. Xenograft mouse models employing transplanted
human hematopoietic cells have also been used, but these are immunodeficient and thus not ideal. As pet dogs
with spontaneous cancers have been increasingly used as a preclinical translational model, we asked whether
CH may also occur naturally in this species. We found that within a cohort of 600 dogs without cancer, 12%
carried a CH mutation, comparable to the rate of CH in humans. Importantly, CH was not detected in dogs less
than 6 months of age and is thus similarly associated with aging. Building upon these findings, the purpose
of this proposal is to credential pet dogs as a relevant tool for studying CH in the context of onco-aging.
Our interdisciplinary team will leverage completed and ongoing studies in pet dogs with cancer to optimize
resources necessary to study CH in this species, interrogate how CH evolves in the context of cancer treatment,
and explore the impact of CH on the tumor immune microenvironment. We will also employ single cell whole
genome sequencing using the new primary template-directed amplification technique to improve sensitivity and
precision of variant calling. Lastly, we will validate findings in dogs using biobanked samples from comparable
human studies. These studies will establish a blueprint for incorporation of CH analytics into canine translational
cancer work, with a future goal of using this unique model system to evaluate novel CH targeted therapies.

Public health relevance
PROJECT NARRATIVE Clonal Hematopoiesis (CH) is a precancerous state that precedes blood cancers and is commonly found in cancer survivors who receive chemotherapy or radiation. Because laboratory mice do not spontaneously develop CH as they age, it has been difficult to effectively study how CH may impact cancer treatment outcomes, particularly in the setting of immunotherapy. Building off our recent finding that like humans, pet dogs naturally develop CH, this proposal will leverage pet dogs undergoing cancer treatment to optimize and validate a suite of tools and resources that will facilitate translational application of data generated in this unique model system.